Pathogenesis of oral microbes triggered by the cyclic deformation of biomaterials

PROJECT SUMMARY
Oral pathogenic biofilms are major drivers of major oral infectious diseases such as dental caries and denture
stomatitis. Currently, the annual cost of treatment of oral biofilm-related infectious diseases exceeds $81
billion only in the US. Strategies to control biofilm formation on dental biomaterials are needed. Biofilm
formation and adhesion are complex processes controlled by the interplay between physicochemical and
biological processes including microbial strain, environmental conditions, and biomaterial surface.
Specifically, biomaterial-biofilm interactions are controlled by different biomaterial surface properties including
wettability, charge density, stiffness, roughness, topography, and chemistry. Biomaterials in the oral cavity
are subjected to cyclic loading from masticatory and biomechanical movements. These repetitive forces can
have an effect in the biomaterial-biofilm interactions. In fact, our recent publications and preliminary results,
we showed for the first time, that the cyclic strain of the biomaterial surfaces is a parameter influencing the
virulence and dysbiosis of oral microbes (Candida albicans and multispecies biofilms), which can lead to the
progression of infection and disease such as denture stomatitis. The overarching goal of this proposal is to
mechanistically study the effect of biomaterials’ cyclic strain on the pathogenesis of oral microbes. In this
study, we will focus on the pathogenesis a fungal strain (Candida albicans) and denture-microbiota. Aim 1 will
study this effect using common materials used in dentures. Aim 2 will explore the phenomena with hard oral
mucosa and Aim 3 with an animal model. This project will help understand how the action of chewing is fueling
the progression of major oral infections such as denture stomatitis, which in turn could lead to the development
of methods for the prevention of pathogenic biofilm formation over implanted medical devices.

Public health relevance
PROJECT NARRATIVE Pathogenic biofilms are surface-attached microbial communities that significantly affect overall and oral health posing challenges to clinical procedures. This project will help us understand how the action of chewing over dental biomaterials influences microbes adhesion, biofilm formation and pathogenesis, and its role on the progression of oral infectious diseases.